Administrative Core

ABSTRACT - ADMINISTRATIVE CORE:
The Administrative Core of the Center for Human Health and the Environment (CHHE) ensures efficient and
effective fiscal and scientific management/leadership of all components of CHHE, and fosters interdisciplinary
collaboration and integration of basic, clinical, public health, and translational research efforts across the
Center. The Administrative Core facilitates expansion and translation of environmental health science
research, especially in areas relevant to the four CHHE Research Interest Groups which are: 1) Emerging
Contaminants, 2) Environmental Genetics and Epigenetics, 3) Pulmonary Health, and 4) Behavior and
Neuroscience, across NC State, East Carolina University (ECU) Brody School of Medicine (BSOM) and North
Carolina Central University (NCCU), a member university of Historically Black Colleges and Universities
(HBCU). The Administrative Core facilitates communication to and from its membership to provide Center
information and receive input on Center services and activities. Through a highly effective, multi-directional
CEC, CHHE and the Administrative Core transmit new knowledge to communities and affected populations
and receive information from the CEC and the Stakeholder Advisory Board (SAB) regarding community
concerns and needs. In addition, the Administrative Core maintains a robust career development program,
providing the foundational funding, intellectual support, collaborative interaction, leadership opportunities, and
practical training essential for our members to become EHS leaders and compete effectively for extramural
research grants, with an emphasis on enhancing the success of early stage investigators (ESIs), mid-career
faculty, women, and members of under-represented groups. The overall goal of the Administrative Core is to
provide the infrastructure that enhances the research impact and capacity of Center membership and to be the
vehicle for multi-directional communication within and between its internal and external stakeholders.